Mechanisms of cardiovascular disease

This is an application for the first competing renewal of a Ruth L. Kirschstein Institutional
National Research Service Award (T32) entitled Mechanisms of Cardiovascular Disease.
Building on the long tradition of NIH-sponsored cardiovascular research training at the Albert
Einstein College of Medicine, this program draws on the talents and experience of 14 faculty
members representing 7 different departments to train young investigators working within 3
areas of thematic focus: 1) Myocardium – Injury and Aging, 2) Vascular Development and
Disease, and 3) Metabolism – Cardiovascular Risk. The mission of this program is to provide
the next generation of investigators, including both pre- and postdoctoral trainees, with state-of-
the art concepts, experiences, and skills required to initiate and sustain successful long-term
independent careers in cardiovascular research. The experience with our first group of trainees
has been gratifying, as these individuals have developed their research projects, presented their
work in both national and international forums, published extensively in high profile journals, and
in several cases, gone on to full-time academic positions for further research. For the next
funding cycle, we plan to build on interactions with academic clinical cardiologists, which have
benefitted our current trainees, and we request the addition of 1 predoctoral training position,
based on the growth of the Einstein Graduate school. We are confident that our program will
continue to produce outstanding new cardiovascular investigators, and thereby contribute to
advances in cardiovascular health in the US and around the world.

Public health relevance
Cardiovascular disease remains the major cause of death in the US and around the world. Improvements in prevention and treatment for cardiovascular disease will come from research in multiple areas, encompassing basic laboratory research, human population studies, and clinical investigation. The goal of this program is to train the next generation of cardiovascular investigators across this range, so they gain the skills, concepts, and experiences required to initiate and sustain successful long-term independent careers dedicated to decreasing the burden of cardiovascular disease in our society.